Hyperpolarized 129Xe MRI to identify structural determinants of low lung function and respiratory symptoms in young adults from the Lung Health Cohort

PROJECT SUMMARY/ABSTRACT
Chronic lung disease is a leading cause of disability and death, in large part because it is often diagnosed after
irreversible lung damage has occurred. The American Lung Association (ALA) Lung Health Cohort (LHC) was
funded by NHLBI to elucidate factors associated with peak lung health and the early deviations from lung
health that may progress to chronic lung disease. The LHC will be collecting spirometry, nasal epithelial
transcriptome, and CT imaging, alongside comprehensive environmental exposure, socio-behavioral, fitness,
and residential history in a nation-wide cohort of 4000 young adults between the ages of 25 and 35. Despite
this wealth of information, there is concern that the earliest stages of disease may go undetected in the LHC,
as early disease is thought to originate in the most distal airspaces, regions which the LHC testing regimen is
unable to probe. To that end, we are proposing an ancillary study to the Lung Health Cohort in which we aim to
collect hyperpolarized 129Xe MRI in a subset of LHC participants. Hyperpolarized 129Xe MRI (Xe-MRI) is a novel
imaging technique that can be used to measure lung structure and function. Specifically, Xe-MRI can be used
to image airway function (“ventilation imaging”), alveolar-airspace size (“diffusion imaging”), and pulmonary gas
exchange (“gas exchange imaging”). Notably, these imaging techniques are able to prove structure and
function in the smallest airspaces of the lungs. As such, Xe-MRI is expected to be sensitive to the earliest
manifestations of pulmonary disease and thus complements the information being acquired by the LHC. In this
sub-study, we will use Xe-MRI to image 260 LHC participants across 6 of the 17 sites involved in the parent
LHC. In aim 1, we will use Xe-MRI diffusion imaging to assess the pulmonary microstructure in LHC
participants with low normal (<85% predicted) lung function. By doing so, we aim to determine the structural
basis of deviations from peak lung health. In aim 2, we will use Xe-MRI to assess pulmonary structure and
function in LHC participants with respiratory symptoms (cough, sputum, wheeze, dyspnea). By doing so, we
aim to elucidate structural and functional determinants of respiratory symptoms that are poorly explained by
clinical markers such as spirometry and CT imaging. The expected outcome of this study is to identify
structural and functional abnormalities that are associated with the clinically measurable deviations from peak
lung health (low normal lung function and respiratory symptoms). Such information will ultimately provide a
treatable target for these individuals. Moreover, as the LHC intends to follow participants longitudinally, we
expect to be able to link early structural and functional abnormalities to the development of chronic lung
disease. Ultimately, our ability to measure lung structure and function using Xe-MRI in young adults at the
ages of peak lung health will enable the identification of disease prior to the development of irreversible lung
damage, allowing clinicians to transition from palliation to prevention of chronic lung disease.

Public health relevance
PROJECT NARRATIVE Chronic lung disease is thought to originate from the most distal airspaces, but clinical measures such as spirometry and CT are unable to probe these regions directly. In this ancillary study to the NHLBI-funded Lung Health Cohort, we will use hyperpolarized 129Xe MRI to assess alveolar structure and function in young adults at the ages of peak lung health. In doing so, we aim to determine the structural basis for low normal lung function and unexplained respiratory symptoms that may be the precursors to chronic lung disease.